The CONNECT-AD Study: Communication and Network Navigation for Effective Care Teams in Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD)

PROJECT SUMMARY
Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD) are leading causes of morbidity,
mortality, and excess healthcare costs. Care for AD/ADRD patients requires multiple providers, often hindered
by fragmented communication. As treatment options continue to expand and an aging population with frequent
comorbidities, challenges in care coordination will multiply and represent an urgent need in healthcare.
In our prior work we have found that digital tracings of communication network structures identified within the
Electronic Health Record (EHR) predict cancer patients’ outcomes (e.g., ED visits, mortality), hence we are
developing scalable EHR tools to improve cancer patients’ care. Our results in cancer provide a strong
foundation for studying AD/ADRD patients, given similarities in the complexity of care coordination across
multiple providers and specialties. This study of persons with AD/ADRD expands on our prior work in cancer by
factoring in the longer-term nature of AD/ADRD patient care and adding a significant new dimension to the
care team: patient and caregiver communications via EHR patient portals.
We will leverage social network analysis, machine learning (ML)-assisted visual analytics, and qualitative
methods to study EHR communication structure data at three University of California health systems that all
use Epic. Pilot analyses identified N=30,523 AD/ADRD patients with over 2.7 million patient/caregiver portal
messages and 108,709 healthcare providers asynchronously accessing their digital records. We focus on one
modifiable dimension of team communication, information sharing via EHRs.
Aim 1: Develop the first multisite database of EHR multiteam system communication in AD/ADRD care,
incorporating novel social network measures to describe and quantify within- and between-group collaborative
patterns in intricate EHR interactions.
Aim 2: Analyze the association between targeted EHR communication structures and quality outcomes
through social network analyses, focusing on preventable ED visits and unplanned hospitalizations in
AD/ADRD care.
Aim 3: Utilize machine learning-assisted techniques to characterize and assess collaborative care dynamics,
identify EHR communication structures associated with poor quality outcomes, and predict patient outcomes
and events.
Aim 4: Apply qualitative methods to deepen our understanding of the findings from Aims 1-3, exploring how
and why communication structures and teaming patterns impact collaborative care delivery.
Multisystem healthcare teams and communication structures need to be understood and then designed much
more intentionally and based on evidence. Our innovative methods will provide data to help us improve our
fragmented healthcare system and ensure quality care.

Public health relevance
PROJECT NARRATIVE Alzheimer's Disease and Alzheimer's Disease Related Dementias (AD/ADRD) pose a significant public health challenge and ranks as the fifth leading cause of mortality in the United States among individuals aged 65 and older. This study will investigate the effects of collaborative efforts within healthcare settings, focusing on how communication and the exchange of information among networks of healthcare providers impact patient outcomes. The insights gained from this study will provide novel data on communication metrics within healthcare multiteam systems and advance the development of future interventions designed to enhance communication and teamwork across different healthcare professions.